Bioinformatics Tools and Services at NCBI for Combating Antibiotic Resistant Bacteria Research

Currently, NCBI provides several AMR services and resources including the NIH National Database of Resistant Organisms (NDARO), an AMR reference gene collection, a tool to identify AMR genes (AMRFinderPlus) in bacterial genomes, and an AMR gene allele nomenclature service for beta-lactamases, mobile colistin resistance, and quinolone resistance.